Optical Sequencing to Link Quantitative Bacterial Phenotypes to Human Mutations

Numerous bacterial pathogens, such as Legionella pneumophila, grow within host cells during
disease. Pathogen growth within cells allows them to grow in a protected site, sequestered from attack by
inflammatory cells and protected from antibody attack. In spite of these advantages, the host cell has a
number of defenses that can attack the intracellular pathogen. These include degradative processes, such
as autophagy which can sequester pathogens in antimicrobial compartments, as well as innate immune
sensing systems that directly attack and kill the pathogen within the host cell cytoplasm. One strategy for
avoiding these attacks in the host cytoplasm is for a pathogen to construct a membrane-bound
compartment that provides a niche for replication. These organisms are called intravacuolar pathogens. To
understand how intravacuolar pathogens such as L. pneumophila establish their niche and continue to grow
in this site, the host proteins that are involved in promoting and restricting growth must be identified. The
usual strategy for identification of these proteins is through mutational analysis. Unfortunately, current
strategies for evaluating the effects of host mutations on pathogen growth have significant shortcomings.
These shortcomings include an inability to identify important host proteins as well as a lack of quantitative
approaches to measure the alteration of pathogen properties within mutant cells. This application proposes
to overcome these problems by linking quantitative measures of pathogen traits, such as fitness, to host cell
mutations.
The experiments described here propose to quantitatively link L. pneumophila intracellular traits to
host CRISPR/Cas9 guide mutations using optical sequencing. As outlined, two different L. pneumophila
traits will be measured by low-power fluorescence microscopy. The host mutations that cause the changed
property of the pathogen will be identified by performing DNA sequencing on the guide, followed by
microscopic identification of each sequencing run. This will allow the gene targeted by the mutation to be
linked to the behavior of the bacterium. In the first set of experiments, the trait followed will be iron
starvation. Mutations will be identified by optical sequencing that prevent the host cell from restricting iron
access to Legionella pneumophila, using a fluorescent reporter system for iron starvation. The second set
of experiments will link pathogen fitness directly to the host mutation, by measuring accumulation of
fluorescent bacteria. To this end, CRISPR/Cas9 editing of genes that alter host mitochondrial function will
be targeted. By successful completion of these goals, a generalizable strategy will be developed that can
be applied to all intracellular pathogens, allowing linkage of quantitative pathogen phenotypes to host
mutations.

Public health relevance
Many pathogenic bacteria grow within human cells as a critical step in the disease process. Although much progress has been made in identifying the pathogen proteins that cause disease, the host proteins that modulate this battle have been difficult to identify. This application proposes to overcome this block by using a strategy to link quantitative behaviors of the pathogen to host cell mutations, using a standard laboratory microscope to perform DNA sequencing.